Multivalent Small Circular mRNA Vaccines for Melanoma Combination Immunotherapy

Abstract
Melanoma is the most serious type of skin cancer. Although immune checkpoint blockade (ICB) therapy has
benefited many melanoma patients, most patients do not respond to current ICB. Vaccines can promote ICB
therapeutic efficacy by generating or amplifying tumor-reactive T cells. Conventional vaccines are associated
with limitations such as low stability and bioavailability, preexisting anti-viral-vector immunity, weak antigenicity,
or concerns over genomic integration or virulent reversion. mRNA vaccines hold a great potential for cancer
immunotherapy. Yet, current linear mRNA vaccines are still associated with 1) limited biostability, despite
structural and nucleoside modifications, and the resulting limited shelf-life and moderate antigen translation
efficiency, 2) complicated, time-consuming, and error-prone enzymatic mRNA production, 3) limited loading
capacity in nanocarriers, and 4) short immune memory. To address these limitations, we propose developing
novel, highly stable, modification-free multivalent small circular mRNA (circRNA) to elicit potent and durable
antitumor immunity for ICB combination immunotherapy of melanoma. Small circRNA is comprised of minimal
RNA elements to translate peptide antigens. We showed that 1) small circRNA has high loading capacity in
nanocarriers and efficiently accumulates in lymph nodes and antigen-presenting cells; 2) terminus-free small
circRNA, either free or loaded in nanoparticles, are highly stable relative to current state-of-the-art modified
mRNA vaccine; 3) circRNA vaccines are self-adjuvanted due to intrinsic activation of intracellular pattern
recognition receptors; 4) circRNA prolong antigen translation accompanied by innate immunostimulation, which
promotes T cell responses; 5) circRNA may produce concatemeric long peptide antigens that, relative to minimal
antigens, undergo proteolytic processing for optimal antitumor T cell responses; and 6) low-dose small circRNA
vaccines outperform several current state-of-the-art modified mRNA vaccines to generate potent and durable T
cell immunity. Further, a multivalent circRNA vaccine elicited significantly potentiated ICB therapeutic efficacy of
melanoma in mice. The objective of this project is to develop and test multivalent melanoma circRNA to elicit
multivalent antimelanoma T cell responses and reduce melanoma tumor immunosuppression, elucidate their
molecular and cellular mechanisms to elicit innate and adaptive antitumor immunity, and assess their melanoma
therapeutic efficacies and toxicity in mice. Our highly collaborative team has complementary expertise in circRNA
vaccine, melanoma vaccinology, and clinical melanoma immunotherapy for accomplishing our scientific goals.
If successful, a significant deliverable from this study is to establish a scientific framework for using this novel
mRNA vaccines in melanoma combination immunotherapy.

Public health relevance
Narrative Advanced melanoma is the most serious type of skin cancer with poor prognosis. Here, we propose to investigate multivalent small circular RNA vaccines that generate potent and long-lasting immune responses for melanoma combination immunotherapy. The results from this project are anticipated to define the design guidelines of these novel vaccines and ultimately improve the clinical practice and outcomes of current melanoma treatments.